Improving Literacy Outcomes in Children who use AAC

Project Summary
Individuals with severe disabilities who cannot use speech to communicate and use augmentative and alternative
communication (AAC; pointing to pictures, using a speech-generating device) are at high risk for life-long health
issues that are exacerbated by illiteracy and limited communication skills. Over 90% of these individuals leave
high school illiterate, resulting in reduced communication skills and a higher probability of life-long health issues.
Our long-term goal is to improve literacy outcomes in individuals who use AAC, and in doing so, improve health
and well-being outcomes. Daily instruction in literacy practices that are evidence-based have the potential to
change the current poor outcomes, yet limited effectiveness research exists related to literacy interventions that
include phonics-based tasks that are adapted specifically for individuals who use AAC. To improve reading
outcomes, it is essential to explicitly teach how sounds in words work (phonemic awareness) and how those
sounds connect to letters they see in print (phonics). Yet, the majority children who use AAC are provided literacy
instruction solely in sight words using memorization strategies. The ALL (Accessible Literacy Learning)
technology has the potential to improve early literacy skills. It is an evidence-informed literacy curriculum that
includes literacy instruction specifically adapted for individuals who use AAC. Research using components of
the ALL curriculum have been conducted, yet prior to our pilot studies, no research has been conducted with the
ALL technology. There is a critical need to understand the effectiveness of literacy interventions that are
specifically adapted for individuals who use AAC. The objective of this application is to examine the efficacy and
feasibility of the ALL technology on a larger-scale through these aims: (1) Assess the effectiveness of the ALL
technology on six early literacy skills for children ages 4-10 who have intellectual and developmental disabilities
and use AAC, and, (2) Assess the acceptability, feasibility, and adoptability of literacy lessons using the ALL
technology to evaluate components that are helpful or hindering to adoption of the ALL technology. The proposed
research will make important advances in the science associated with teaching children who use AAC how to
learn to read. This project is innovative in three ways: (1) the ALL technology provides phonemic and phonics-
based literacy instruction to a population that does not typically receive this instruction due to their inability to
speak; (2) the intervention targets multiple literacy skills, which may contribute to better literacy outcomes.
Teaching multiple skills during a lesson could potentially improve both the rate and the amount of literacy skills
acquired; and, (3) the ALL technology uses automated data-driven decision making with materials adapted for
individuals who use AAC – addressing many implementation challenges documented by service providers. The
expected outcomes of the project include efficacy of the ALL technology, as well as sufficient data in six early
literacy skill areas; foundational for a future R01 that improves the provision of evidenced-based literacy and
maximizes literacy outcomes for children who use AAC.

Public health relevance
Project Narrative Individuals who cannot use speech and use augmentative and alternative communication (AAC; pointing to pictures, using a speech-generating device) have limited opportunities in phonics-based literacy instruction. Acquiring even basic literacy skills can lead to increased employment opportunities, improved safety and well- being, and enhanced social engagement. This project aims to investigate the efficacy, feasibility, acceptability, and adoptability of a technology-mediated phonics-based literacy intervention (ALL; Accessible Literacy Learning) to increase six basic literacy skills of individuals who use AAC.